Mechanism of intestinal TET3-mediated DNA oxidation and transcriptional regulation

PROJECT SUMMARY
DNA methylation dynamics in mammals are an integral component of the epigenetic regulatory machinery.
Methylated DNA functions as a repressive mark for gene expression and essential for cell fate determination
during embryonic development. In adult tissues, DNA methylation at specific genomic loci is essential for the
maintenance of cellular identity and function. Changes of DNA methylation profiles in intestinal epithelial cells
(IECs) were observed upon colonization by commensal microbiota. However, how environmental cues including
the microbiota, enteric pathogens and chemical stressors affect DNA methylation patterns in the intestinal
epithelia, remains largely unclear. DNA methylation is catalyzed by DNA methyltransferases targeting cytosine
at the 5th carbon position resulting in 5-methylcytosine (5mC). DNA methylation can be actively removed via
successive DNA oxidations of 5mC into 5-hydroxymethylcytosine (5hmC), 5-formylcytosine (5fC), and 5-
carboxylcytosine (5caC) catalyzed by the ten-eleven translocation (TET) family of DNA dioxygenases, TET1,
TET2 and TET3. Both 5fC and 5caC can be excised by thymine DNA glycosylase (TDG) as part of the DNA
base-excision repair mechanism resulting in unmodified cytosines. Both TET and TDG have been associated
with high risk of intestinal bowel disease development. However, the role of TET-mediated DNA oxidations in
intestinal epithelial physiology remains unexplored. We find that TET3 protects IECs against pro-inflammatory
stressors including the enteric pathogen Salmonella typhimurium and the chemical-induced colitis model dextran
sodium sulfate (DSS). We identified a TET3-dependent reprogramming of gene expression profiles in IECs in
response to pro-inflammatory luminal stressors resulting in the upregulation of genes involved in Wnt and Notch
signaling pathways. TET activity depends on the metabolite -ketoglutarate (KG) to oxidize 5mC into 5hmC,
5fC and 5caC. We hypothesize that in response to luminal signals such as KG, TET3-mediated DNA oxidations
act as integral epigenetic and transcriptional regulators to maintain IEC homeostasis and protect from luminal
stressors. Mechanistically, we propose a distribution of labor among TET-mediated DNA oxidations whereby 5fC
and 5caC, whose levels are dynamically regulated by TETs and TDG, promote transcriptional pausing of stress-
responsive genes involved in epithelial repair and innate defense programs, whose transcriptional pausing state
may be released by TDG-mediated excision of 5fC/5caC followed by enrichment of 5hmC levels. To address this
hypothesis, we generated mouse models with Tet3 specific deletion in IECs, Paneth cells or intestinal stem cells.
We will implement diverse genome wide approaches to decipher gene networks whose expression is regulated
by TET3-mediated DNA oxidations affecting transcriptional pausing in response to commensal microbiota and
luminal stressors. This project is innovative because it will decipher the epigenetic and transcriptional
mechanisms that are dependent on the KG-TET-TDG axis to maintain homeostasis and protect the intestinal
epithelial lining against pro-inflammatory conditions.

Public health relevance
PROJECT NARRATIVE Intestinal epithelial cell DNA methylation patterns, which can be reversed by the ten-eleven translocation (TET) enzymes, can be altered by microbiota. How TET-mediated DNA oxidation dynamics affect mucosal innate immune response and inflammatory susceptibility are unknown. This MPI project uses mouse genetics and DNA epigenetic approaches to elucidate the contribution of TET-dependent DNA oxidations for the function of intestinal epithelial cells, Paneth cell and intestinal stem cells.